Investigating Mechanisms of Hyperprogression on Anti-PD-1 Immunotherapy

Abstract
The number of cancer patients being treated with checkpoint blockade immunotherapy (CBI) targeting the PD-
1/PD-L1 pathway is increasing dramatically. Recently a novel and unfavorable response pattern termed
hyperprogression (HPD) has been identified which is characterized by a rapid worsening and acceleration of
tumor growth after starting CBI. Our group was the first to report the genetic alterations associated with HPD,
namely MDM2 amplifications and EGFR alterations. However, mechanisms of action or strategies to
circumvent HPD have not been reported. Using novel tumor models, our preliminary data has identified that
MDM2 amplified cells are hypersensitive to TNFα induced proliferation compared to non-MDM2 amplified
tumor lines. Mechanistically we have identified that MDM2 amplification dramatically alters TNF-alpha signaling
pathways, blocking apoptotic signals while simultaneously promoting NFκβ mediated cell growth and
proliferation. In this study we will elucidate mechanisms of HPD and determine whether MDM2 amplification
alone is sufficient to cause HPD and whether HPD can occur with other checkpoint blockade agents. We will
then test whether novel MDM2/4 or TNFα inhibitors can block or prevent HPD in our unique tumor models. Our
hypothesis that MDM2 amplified tumors are resistant to TNF-alpha induced apoptosis and hypersensitive to
TNFα induced cell cycling which results in uncontrolled proliferation and HPD after treatment with CBI.
Together these studies will significantly improve our mechanistic understanding of HPD and identify targeted
drug strategies that can be rapidly translated into clinical trials to improve outcomes in cancer patients treated
with CBI.

Public health relevance
Narrative Hyperprogression (HPD) is a novel and unfavorable response pattern characterized by rapid and accelerated cancer growth observed during treatment with anti-PD-1/PD-L1 checkpoint blockade immunotherapy (CBI). Here we focus on studying the mechanisms underlying HPD and testing novel drug combinations to prevent HPD. Our studies will improve our mechanistic understanding of HPD and lead to the discovery of novel targeted strategies which could be rapidly translated into clinical trials to prevent HPD and improve outcomes in cancer patients treated with CBI.